Cleveland Clinic Orthopaedic and Rheumatology Care -- Quality Innovation Summit 2

DESCRIPTION (provided by applicant): Abstract: The 2009 Cleveland Clinic Orthopaedic and Rheumatology Care - Quality Innovation Summit, May 13-15, 2009, is a 2 1/2 day multidisciplinary conference devoted to exploring the current state-of-the-art in the assessment and management of quality in Musculoskeletal Medicine from the perspective of each of the stakeholders in this process. Musculoskeletal disorders are the leading cause of disability in the United States, with one in every seven Americans afflicted with an impairment of the bones or joints. Each day, millions of Americans endure such conditions as osteoarthritis, rheumatoid arthritis, and osteoporosis, with the resulting pain, disability, and medical expense inflicting tremendous burdens on individuals, families, and society. Moreover, the impact of musculoskeletal conditions is expected to grow as the American population increases and ages in the coming decades. In response to this dramatic growth in patient populations and increase in the complexity of musculoskeletal diseases, the number of new drugs and devices, as well as therapeutic protocols to treat those diseases, has also increased. This evolution in treatment technologies has necessitated a new look at the methodology and metrics for measuring patient outcomes and patient satisfaction. This meeting is the first of its kind in orthopaedics and rheumatology, bringing together physicians, quality management specialists, public health professionals, information technology experts, government officials and patient safety advocates to address the "How and Why" of quality measurement.

Public health relevance
Project Narrative: The 2009 Cleveland Clinic Orthopaedic and Rheumatology Care - Quality Innovation Summit, May 13-15, 2009, is a 2 1/2 day multidisciplinary conference devoted to exploring the current state-of-the-art in the assessment and management of quality in Musculoskeletal Medicine from the perspective of each of the stakeholders in this process. This includes: patients, physicians, institutions, professional societies, public and private payers, regulatory agencies, non-government organizations, patient safety organizations, the device and pharmaceutical industry, funding agencies, as well as key components of State and Federal government. The Summit will enable participants to building a shared understanding of the vocabulary, issues, and competing and common interests and visions shaping both the practice of Musculoskeletal Medicine. Participants will also join in a dynamic forum to explore and shape discussion regarding the optimal context and systems with which to assess the quality and value of Musculoskeletal Care, and to consider mechanism by which these measures can an should be used to design and optimize the process of care and the most effective means of linking performance to reimbursed in the future. In this environment summit participants will join in the examination best practices, evolving innovations and models for quality assessment and management, and explore areas of synergy that may enable collaboration and the forging of effective partnerships that best serve the future of Orthopaedics, Rheumatology and Musculoskeletal Medicine. The Cleveland Clinic seeks funding to offset the costs associated with audio-visual capture and recording of the event, as well as for production of written materials that will serve as "take-away" and downloadable support for on-site and remote participants.